Community Engagement Core

ABSTRACT: COMMUNITY ENGAGEMENT CORE
CoEC facilitates alignment of the goals and activities of the Center with stakeholder needs for actionable
scientific knowledge that addresses the concerns of the communities we serve. CoEC fosters durable
relationships between stakeholders (New Jersey communities, health professionals, and policymakers) and
CEED scientists. Through these relationships, bidirectional communication enables scientists to learn about
community knowledge, issues, and perspectives, and stakeholders to learn about CEED science and
capabilities to address community concerns. This communication forms the basis for PEH research that
addresses issues of concern to communities with the goal of targeted intervention and prevention strategies to
reduce exposures and/or prevent adverse health effects. A major goal of CoEC is to empower environmental
justice (EJ), vulnerable, and exposed communities to effect complex systems changes that improve
environmental health. The specific aims of CoEC are to 1) Translate and disseminate Center research to
communities, health professionals, and policymakers through joint activities, projects, and the Stakeholder
Advisory Board (SAB); 2) Promote bi-directional communication between stakeholders and Center
researchers through meetings and development of stakeholder-driven information tools, including print
materials, and interactive social media; 3) Facilitate community-engaged research by fostering stakeholder
and CEED researcher interaction.; 4) Empower communities, health professionals, and policymakers to better
assess environmental health risks using evidence-based, effective, and economically-sound interventions.
CoEC translates and disseminates scientific knowledge and research findings that are responsive to
community needs and that inform decisions by health care providers, stakeholders, policy makers and
regulators.